ADMINISTRATION, BUDGETING AND OPERATIONS

PROJECT SUMMARY (See irstructlons); In this competing renewal P01 application, the Administrative Core will continue to provide centralized grant administration, communication processing, and budget management This Core will also serve to amalgamate the investigators, their experimental findings and their ideas, evaluation of research efforts and also to direct the summary efforts toward the Program outcome. The Specific Aims of the Administrative Core include the following: 1. Provide administrative services to the investigators. This includes the management of project supplies, filing, development of memos, meeting minutes and communications covering all operations, including publications. 2. Organize monthly meetings of the Program Steering Committee to facilitate effective communication and decision making to ensure scientific progress of the Program. 3. Organize an annual External/Internal Scientific Advisory Board meeting. The External and Internal Scientific Advisory Board shall review all experimental findings and clinical outcomes, help prioritize investigations, review the coordination of collaborations, and evaluate concepts that emerge from the studies. 4. Maintain program integration activities. This includes data sharing, rapid publication efforts, and identify and institute other novel activities critical to maintaining and strengthening the integration of the program. 5. Provide overall fiscal review, accounting, and real time budget analyses. This includes reports, verbal communications, reviews and forward-looking projections on expenditures.

Public health relevance
RELEVANCE (See instructions): The Administrative Core is essential for the functions of the Program as an engine for discovery in the human innate immune system and for translating these basic discoveries into rational immunotherapy for the treatment of human cancers.